Analysis of C9ORF72-associated poly (GR) interactions on BAF chromatin remodeling complex structure and function

Project Summary
Frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS) are two fatal
neurodegenerative diseases. The GGGGCC (G4C2) repeat expansion in the chromosome 9 open
reading frame (C9ORF72) constitute the most common form of familial. G4C2 repeat expansions can
generate five different dipeptide repeat proteins (DPRs). The arginine containing DPRs, have shown to
be highly toxic in several in vitro and in vivo models. We have discovered a novel biochemical
interaction between several subunits of the chromatin remodeling complex BRG1/BRM associated
factor (BAF) and the DPR poly (GR). This interaction induces the mis-localization and decreased levels
of several BAF complex subunits. Our hypothesis is that BAF complex dysregulation will induce
changes in BAF complex structure that will concurrently change the chromatin landscape and gene
expression profile in neurons leading to neuronal dysfunction and death. In this proposal we will
elucidate how of poly (GR)-BAF complex interactions, affect the 3-dimensional structure of BAF
complex. The results obtained by cross link mass spectrometry, TurboID analysis, and the chromatin
accessibility profile and gene expression analysis will allow us to gain a more comprehensive and in-
depth understanding of chromatin dysregulation in the pathogenesis of C9ORF72-related FTD. Dr.
Lopez Gonzalez acquired extensive experience in the use of induced pluripotent stem cells to model
neurodegenerative disease during his training as graduate student and postdoctoral training. Dr. Lopez
Gonzalez joined the Department of Neurosciences at the Lerner Research Institute (LRI) of the
Cleveland Clinic in August 2020. To perform his career development and experimental training, he will
devote 75% of his time to research under this k01 award. He will be trained in state of the art
biochemical and epigenetic techniques. The career development training include 1) attending to career
development workshops organized by the LRI, 2) seminars and journal club organization 3) responsible
conduct of research courses and 4) presentations in national and international conferences. To
establish a strong research program and prepare for competitive NIH funding, Dr. Lopez Gonzalez will
be mentored by Dr. Paul Fox. Staff, Cardiovascular and Metabolic Sciences Department and Robert
Canova Endowed chair in Inflammation Research Lerner Research Institute, Cleveland Clinic. Dr. Fox
has extensive experience in studies of post-transcriptional mechanisms controlling gene expression
and cell function. His co-mentor will be Dr. Thomas Fazzio Professor at the Department of Molecular,
Cell and Cancer Biology at the University of Massachusetts Medical School his laboratory has develop
several new epigenomic methods. Dr. Lopez Gonzalez will meet with his mentor and co-mentor on a
monthly basis to discuss the advances of his project, and to receive guidance with career development.

Public health relevance
Project Narrative Frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS) are two fatal neurodegenerative diseases, and a repeat expansion mutation in the chromosome 9 open reading frame (C9ORF72) constitutes the most common form of familial FTD and ALS. Repeat expansions can generate five different dipeptide repeat proteins (DPRs), and we have found that these the DPR, poly (GR) can interact with the chromatin remodeling complex BRG1/BRM-associated factor (BAF), inducing a decrease the levels of this chromatin regulator. In this proposal, we will analyze how this interaction affect complex structure and the capacity to modify chromatin status and gene expression in patient-derived iPSCs derived neurons and its effects on neuronal survival and function.